Non-viral gene therapy with eCD4-Ig

ABSTRACT
We are developing non-viral gene therapy with eCD4-Ig as a practical approach for suppressing HIV
replication for a lifetime after a one-time intramuscular injection. The error-prone nature of reverse
transcriptase, and the sequence plasticity of the HIV envelope glycoprotein (Env), result in the rapid escape
of neutralizing antibodies and daunting levels of global antigenic diversity. The antigenic diversity of HIV and
ease of escape of antibody responses can be countered with eCD4-Ig, which is an antibody-like therapeutic
protein constructed from parts of HIV’s primary receptor (CD4) and coreceptor (CCR5). eCD4-Ig functions
like a broadly-neutralizing antibody (bNAb) in being able to neutralize virus infection and mediate effector
functions, but cannot be escaped without HIV sacrificing its ability to bind its receptor and coreceptor. Here,
we propose developing a non-viral gene therapy platform and its use to sustain therapeutically-effective
plasma concentrations of eCD4-Ig for potentially a lifetime after a single administration. We propose basic
science experiments that will inform the development of this non-viral gene therapy platform, plus the
development of approaches for enhancing the efficiency of gene transfer into skeletal muscle. The proposed
studies build on our work with adeno-associated virus (AAV) vectors to establish a state of long-term viral
remission where further treatment is not required to suppress plasma viral loads to levels that are
undetectable using standard assays. We and others term such a state of long-term viral suppression, albeit
one short of eradication, a ‘functional cure.’ The lifelong expression of therapeutic concentrations of eCD4-
Ig after a one-time intramuscular administration of a non-viral gene therapy vector is a feasible means of
achieving a functional cure for HIV.

Public health relevance
NARRATIVE A ‘functional cure’ for HIV is defined as a therapy capable of suppressing HIV replication for a lifetime after a one-time treatment. We are working to develop a functional cure for HIV based on vectors expressing an antibody-like therapeutic known as eCD4-Ig. Here, we will develop a non-viral vector that may be substantially more consistent and less expensive to manufacture than viral vectors.